Cerebellar-Related Time Perception Deficits in the Fragile X Rat Model

Fragile X syndrome (FXS) is the most common inherited form of intellectual impairment and monogenetic cause of autism, with some 30% of people with FXS also meeting the criteria for autism. The cause of FXS is the loss of expression of the fmr1 gene, which is highly expressed in cerebellum, making it likely that cerebellar dysfunction contributes to the FXS phenotype. The cerebellum is typically associated with motor coordination, and indeed, motor impairments are common in FXS. However, multiple lines of evidence have now clearly demonstrated the importance of the cerebellum for many cognitive functions, strongly suggesting that cerebellar dysfunction contributes more broadly to the behavioral impairments seen in FXS. And yet, little is known about cerebellar function in FXS, a significant gap our overall understanding of FXS. Thus, investigating how cerebellar activity is altered and how this affects behavior are the overarching goals of this project. Parts of the cerebellum link up with prefrontal cortical areas that are involved in cognitive functions, including time perception, and our preliminary data indicate that cerebellar activity influences time perception. Our data also show that time perception and the learning of timing discriminations are impaired in the fmr1 rat, an animal model of FXS. Thus, we propose to use the fmr1 rat to investigate changes in cerebellar physiology in FXS and to relate such changes to impaired learning and use of temporal information. We will use a timing discrimination task called temporal bisection in which the animal has to determine whether a test cue (e.g., a tone) is closer in duration to either a previously learned short or long duration cue. We will compare both the learning rates and overall performance levels attained on several variations of this task between wildtypes and fmr1s. These results should shed light on the nature of the learning and perceptual impairments in FXS. Next, we will investigate whether manipulations in cerebellar activity can ameliorate the learning and perceptual abnormalities we have found in fmr1 rats. Preliminary results show we can alter an animal's perception in specific ways by modifying cerebellar activity optogenetically. We will thus use optogenetic techniques to modify the activity of cerebellar Purkinje cells and nuclear neurons while fmr1 rats perform the bisection task to see if we can 'normalize' their perception of the duration of sensory stimuli. We will also manipulate cerebellar activity during the learning of the temporal bisection task to try to increase their learning rate. Finally, we will characterize cerebellar activity in vivo in awake fmr1 rats. Because virtually nothing is known about cerebellar activity in FXS, we will record from both the cerebellar cortex and nuclei and analyze both spontaneous activity (to investigate baseline abnormalities) and activity from when animals are performing the temporal bisection task (to investigate abnormal timing-related activity). In sum, the proposed experiments should provide new information about cerebellar dysfunction in FXS that could guide or suggest new treatments.

Public health relevance
Project Narrative Cerebellar pathology and clinical signs of cerebellar dysfunction are found in fragile X syndrome (FXS), specifically, a common genetically-identified cause of autism, and the gene, fmr1, whose loss of expression leads to FXS is normally strongly expressed in the cerebellum; yet, little is known about how cerebellar physiology is altered in FXS or how cerebellar dysfunction contributes to the FXS phenotype. Our experiments should help fill this gap by investigating the behavior and neuronal activity of the cerebellum of the fmr1 rat model of FXS. Moreover, the proposed experiments will test whether altering cerebellar activity optogenetically can correct learning and timing deficits in the fmr1 rat, potentially providing a basis for developing treatments for this disease.